STUDYING INTRA-INDIVIDUAL PAIN VARIABILITY IN SICKLE CELL DISEASE AND RESOLUTION OF PAIN AFTER HEMATOPOIETIC CELL TRANSPLANT: A NOVEL MODEL SYSTEM TO ELUCIDATE MECHANISMS OF TRANSITION TO CHRONIC PAIN

PROJECT SUMMARY (FROM PARENT K23 APPLICATION) Sickle Cell Disease (SCD) affects over 100,000 individuals in the U.S, mostly from minority ethnicities, leading to significant morbidity and poorer quality of life, often due to recurrent and chronic pain. The mechanisms of transition from recurrent acute pain episodes to chronic pain are poorly understood. Although pain has been measured with surrogate markers such as healthcare utilization for pain and as markers of disease severity, these grossly underestimate the true burden and impact of pain on functioning and patient-reported outcomes (PROs) in patients with SCD. The candidate and her mentor have developed and established content validity of a web-based electronic pain diary which captures pain on a momentary level, in the patient’s natural environment. Intra-individual variability in pain intensity, distinct from pain intensity, is becoming recognized as an independent and important facet of the pain experience. Hematopoietic Cell Transplantation (HCT) provides a unique model for the study of chronic pain where the underlying sickling and vasocclusion are removed by HCT. Preliminary data suggest that not everyone experiences resolution of pain after cure. The candidate will use the framework of two large NIH-sponsored multi-center clinical trials of HCT for SCD to address critical knowledge gaps in SCD pain and the relevance of pain variability on PROs, and on identifying phenotypes of pain (Aim 1). In Aim 2(a), she will study the role of pre- HCT pain attributes and post-HCT complications on pain resolution after cure of SCD. Using advanced statistical models, she will define trajectories of pain resolution following HCT with the goal to identify predictors of persistent pain after cure, and identify the patients whose pain is most likely to benefit from HCT. In Aim 2b of this proposal, using Quantitative Sensory Testing (QST) methods, she will investigate whether indicators of central sensitization persist in those with persistent pain after cure of SCD, providing novel insights into chronic pain in SCD. In Aim 3, she will, for the first time, determine the feasibility of a prospective, longitudinal study of development of chronic pain in SCD. The candidate has a unique research niche at the crossroads of SCD, pain and health outcomes research and is seeking to use an innovative approaches to advance the field of chronic pain. She is also uniquely qualified as one of the few SCD pain researchers skilled in QST methodology. This proposal envisages that the candidate will acquire expertise in advanced statistical methods through didactic courses and application in mentored research, gain experience managing the acquisition of pain and PROMIS endpoints in large multicenter trials, and in prospective, longitudinal observational studies. Her advisory committee consists of experts in SCD (Dr. Lakshmanan Krishnamurti, Dr. Wally Smith, and Dr. Clinton Joiner), HCT for SCD (Dr. Lakshmanan Krishnamurti, and Dr. Edmund Waller), and biostatistical methods for modeling of longitudinal diary data (Dr. Courtney McCracken), with a long-standing mentoring relationship and commitment to her research success. Emory University provides an outstanding research environment and has committed requisite resources and support to the candidate.

Public health relevance
NARRATIVE (FROM PARENT K23 APPLICATION) There is limited understanding regarding why some patients with sickle cell disease (SCD) experience chronic pain, which is associated with significant morbidity, and healthcare costs. By studying pain data captured using electronic pain diaries, we will study the importance of attributes of pain such as intra-individual pain variability, and also the persistence of pain in patients after cure of SCD by bone marrow transplant. We will also study experimental pain sensitivity in SCD to identify underlying mechanisms of chronic pain, in the setting of curative transplant, and in a prospective study following adolescents with SCD for the development of chronic pain.